Systems-level identification of host determinants of patient outcomes in Lassa fever and Ebola

Project Summary / Abstract
The Eastern Province of Sierra Leone has the world’s highest incidence of Lassa fever. Members of this
research team have been working on Lassa fever at the Kenema Government Hospital (KGH) for over twelve
years. The 2013-16 West African Ebola epidemic began less than a four-hour drive from KGH and was the
ﬁrst Ebola outbreak to occur in an area close to an existing facility for viral hemorrhagic fever basic and
clinical research. KGH manages up to 600 suspected Lassa fever patients per year, and Kenema and
surrounding districts experienced a large number of Ebola case. We will leverage existing samples from these
established cohorts of humans infected with Lassa fever or Ebola. While it is well established that
asymptomatic or mildly symptomatic infections occur in both Lassa fever and Ebola, it is unknown which host
factors determine the progression to fulminant hemorrhagic fever. Likewise, a substantial portion of Lassa
fever and Ebola survivors develop a plethora of serious sequelae, but factors that predicate these
complications remain elusive. Our research program supports both Lassa fever and Ebola survivor groups.
We propose to integrate experimental approaches and computational modeling to test and validate
hypotheses of signiﬁcance to Lassa fever and Ebola. Our assembled team has a track record of collaboration,
unique expertise with both Lassa virus and Ebola virus and the appropriate multidisciplinary representation in
systems and computational biology, virology, immunology, genomics, proteomics, machine learning,
statistical methods and modeling required to execute the proposed program. Our overall goal in Project 1 is to
generate an integrated dataset that can be used to build predictive models of patient outcomes in Lassa fever
and Ebola. Studies proposed under Speciﬁc Aim 1 will deﬁne physiological attributes that distinguish Lassa
fever and Ebola survivors and non-survivors, and individuals that develop serious sequelae. Speciﬁc Aim 2
will elucidate the evolution and function of successful antibody networks in Ebola and Lassa fever survivors. T
cell dynamics and the role human leukocyte antigens leading to successful clearance of Ebola virus and
Lassa virus will be deﬁned in studies described in Speciﬁc Aim 3. In Speciﬁc Aim 4 we will develop and test
predictive models for the role of host factors in Lassa fever and Ebola outcome. Project 1 on host factors
complements the studies described in Project 2 on viral factors and integrates with and utilizes each of the
Cores.